The role of IL17A and keratinocyte stem cells in human psoriasis.

BACKGROUND: Psoriasis is a benign inflammatory immunological disorder characterized by
hyperproliferation of the epidermis. The role of stem cell (SC) divisional behavior in the hyperproliferation of
psoriasis has not been addressed previously.
PRELIMINARY DATA: As part of our last completed Merit Review we provided evidence to show that while
oncogenic hyperproliferation is associated with symmetric SC divisions (producing increased numbers of SCs),
benign hyperproliferation is associated with increased asymmetric SC divisions (no change in SC number). In
studies subsequent to the previous Merit, we showed that the increase in asymmetric SC divisions in psoriasis
was interleukin 17A dependent (Charruyer et al, 2017).
HYPOTHESES: in Aim 1 we hypothesize that the observed increase in SC divisions is due to an increase in
actively cycling SCs rather than a change in cell cycle duration, and that the increase in progenitor transit
amplifying cells (TACs) in the suprabasal layer is a downstream consequence of the change in SC behavior
rather than an increase in 'rounds' of TAC divisions. In Aim 2 we hypothesize that genes associated with
signaling pathways related to SC quiescence and to asymmetric SC division will be differentially expressed in
the SCs of interleukin 17A versus vehicle-treated keratinocytes.
SHORT TERM GOALS: In Aim 1 we will complete studies to fully elucidate how altered SC and TAC kinetics
result in the acanthotic (thickened) epidermis of psoriasis. In Aim 2 we will determine the changes in gene
pathways underlying the altered SC behavior; pathways associated with quiescence and asymmetric SC
division, using RNAseq and then validate these genes/pathways as relevant for psoriasis and for keratinocyte
SC self-renewal using normal and psoriasis human keratinocytes.
LONG TERM GOALS: The studies of Aim 1 are designed to enable a relevant new mathematical modeling of
psoriasis as a future goal. Aim 2 will elucidate molecular mechanisms underlying the alterations in Aim 1 and
provide strategies for manipulation of SC divisional behavior. Along with better understanding
hyperproliferative diseases, these studies will move us closer to important therapeutic goals: to target
quiescent/dormant cancer cells that escape conventional therapies, to decrease SC quiescence/ increase
symmetric SC divisions to aid wound healing, and to restore homeostasis between the balance of asymmetric
and symmetric SC divisions in the treatment of psoriasis and other hyperproliferative diseases.

Public health relevance
These studies will help us understand how and why stem cells divide too much in psoriasis. Understanding how stem cells divide abnormally in disease will lead to novel therapies to manipulate stem cell divisions for the treatment of skin ulcers (too few stem cells), skin cancer (too many ‘cancer’ stem cells), and psoriasis (unbalanced production of stem and progenitor cells). This research has relevance to Veterans’ health and to the cost of care. The health of Veterans with psoriasis is negatively impacted, compared to those with psoriasis in the US population, due to the effects of Veteran lifestyles (stress, PTSD, alcohol and tobacco use) on the severity of psoriasis. Psoriasis is a large economic burden for both the afflicted Veteran and the VA healthcare system. In addition, Veterans are at greater risk for skin ulcerations (a diabetic complication) and some are at increased risk for skin cancer.